Administrative Core

PROJECT SUMMARY/ABSTRACT
The purpose of the Administrative Core is to support the objectives of the MATCHES Telehealth Research Center by serving as the organizational hub to optimize collaboration and scientific interactivity among MATCHES (Making Telehealth Delivery of Cancer care at Home Effective and Safe) investigators. The services centralized in the Administrative Core provide the scientific, administrative, communications, and fiscal infrastructure that serves all components of the proposed P50 Program. The specific aims of the Administrative Core are to: 1) maximize operational efficiency through coordination, communication, execution and oversight of all Center activities; 2) engage and foster synergy and knowledge exchange among Center members; national experts in telehealth and health system performance; and patients, leaders and workforce; 3) provide training opportunities for investigators from different disciplines, equipping them with infrastructure, resources, skills, and mentorship to foster innovation and expand the evidence base for when and how to integrate telehealth into cancer care; and, 4) support Center activities with strong theoretical models, conceptual frameworks, and approaches for implementation and overall impact. The Core will organize meetings and coordinate a Center website to disseminate knowledge; obtain ongoing feedback from both national experts in telehealth and MSK leaders; and engage with stakeholders across all Center activities. The Core will evaluate the capacity for telehealth to enable patients to receive safe and effective oncology care in their own homes using the MSK@Home platform that includes support for laboratory tests, nursing, and pharmacy supervision without necessitating a clinic visit. The Core will track utilization metrics and help implement strategies to support access, including provision of training, equipment, and web access. To fulfill the Center's education and mentoring mission, the Core will recruit postdoctoral fellows and provide opportunities for young investigators to learn from senior researchers in collaboration with the Research & Methods Core. The Administrative Core will be led by M. Morris, MD, K. Panageas, DrPH, and P.D. Stetson, MD, the PIs of MATCHES, with support from a dedicated Center Manager. This Executive Team will share overall authority for the scientific and administrative decision-making and for the day-to-day running of MATCHES. The Core will include six support units—Regulatory and Fiscal Unit, Clinician and Staff Engagement Unit, Patient Engagement Unit, Training Unit, Internal Advisory Board, and External Advisory Board—led by faculty with synergistic expertise. The Core will use cohesive conceptual frameworks to ensure that the evidence generated by Center investigators builds on existing knowledge and is informative for the design of telehealth-based cancer care delivery worldwide.